Integrating Genetics and Socio-Environmental Factors to Predict Disease Progression

PROJECT SUMMARY/ABSTRACT
The trajectory of common, complex diseases is shaped by a dynamic interplay involving genetic and socio-
environmental factors that together profoundly impact public health outcomes. Towards the goal of integrating
genetic insights into precision medicine, PRS have shown promise as clinical tools for population risk
stratification and early detection in highly heritable diseases. However, existing PRS models are often derived
from disease risk-associated loci identified in traditional case-control GWAS which models lifetime risk,
neglecting the critical timing of disease onset. To refine PRS in precision medicine, it is essential to broaden the
genetic study focus from mere susceptibility to include disease progression. This shift is crucial to deepen our
understanding of disease mechanisms, improve diagnosis and prognosis, and develop targeted therapies. This
expanded scope emphasizes the importance of time-to-event (TTE) factors and the critical yet often overlooked
socio-environmental factors, which influence health outcomes throughout the disease course.
To address these needs, this project will advance the predictive models of disease progression by
developing and applying statistical frameworks that integrate genetic and socio-environmental factors, utilizing
rich genetic and longitudinal healthcare data in modern multi-ancestry biobanks. Targeting 16 exemplar TTE
phenotypes, the models will be adaptable to various sequential disease progressions. Aim 1 will extend current
PRS models using genome-wide survival analysis (GWSA), which can identify genetic variants affecting both
disease occurrence and progression, to predict TTE phenotypes. This includes developing both single- and multi-
ancestry PRS to improve prediction accuracy and generalizability. Aim 2 will innovate region-based PRS through
set-based association analysis of rare variants, revealing new genetic contributors to progression of diseases by
combining with common variants-based PRS. Aim 3 will integrate genetic predictors from Aims 1 and 2 with a
polysocial score, which encapsulates comprehensive socio-environmental factors, thus enhancing the model’s
precision and offering a holistic understanding of their respective roles in disease progression.
This research is poised to significantly advance precision medicine by deepening our understanding of
disease progression and informing more personalized, effective healthcare strategies. The research and training
plan is meticulously designed to cultivate expertise in four key domains: statistical genetics methods
development, rare variant association analysis, socio-environmental exposure data analysis, and professional
skill enhancement. Conducted under the mentorship from world-renowned scientists, and in an outstanding
research environment at Massachusetts General Hospital and the Broad Institute, this project and the K99/R00
award will be instrumental in propelling the candidate towards an independent research career in medical,
population, and statistical genetics.

Public health relevance
PROJECT NARRATIVE This proposal aims to deepen our understanding of disease progression by integrating genetic predispositions with socio-environmental factors, leveraging advanced statistical frameworks and large-scale biobanks. By developing more accurate and comprehensive predictive models of disease progression, this work has the potential to inform targeted interventions and therapeutic strategies. Ultimately, this project addresses significant gaps in precision medicine, promising to advance public health by enabling more personalized and effective secondary prevention strategies.